A taxonomic articulation-focused approach to dysarthria classification

Articulatory impairments are common in talkers with dysarthria and have been shown to contribute most to
speech intelligibility loss. However, the treatment of articulatory impairments remains challenging; primarily,
because knowledge about articulatory impairment patterns and how they vary across talkers is limited. The
Mayo Clinic dysarthria classification system links neurological conditions to specific, auditory-perceptually
defined dysarthria types with presumably distinct motor impairment patterns. Based on this framework,
prominent textbooks have recommended to specifically target the motor impairments that presumably underlie
each dysarthria type. Such an intervention approach, however, still lacks empirical support and is difficult to
apply to mixed dysarthria types. Based on the rationale that virtually all talkers with dysarthria exhibit imprecise
articulation, impairment-nonspecific behavioral treatments (e.g., loud, clear, slow speech) have gained
popularity and are commonly used as therapeutic interventions for talkers with mild to moderate dysarthria
regardless of their underlying disease. This rationale, however, ignores the fact that a variety of articulatory
behaviors can yield the same auditory-perceptual consequences. Indeed, highly heterogeneous articulatory
performance patterns have been reported across and within disease types and motivated us to test the
feasibility of a new, taxonomic (data-driven) approach to dysarthria classification based on speech kinematic
measures. Our pilot work on a cohort of 28 talkers with Parkinson's disease (PD), amyotrophic lateral sclerosis
(ALS), and multiple sclerosis (MS) revealed six dysarthria subgroups with unique articulatory impairment
profiles addressing temporal and spatial characteristics of vocal tract adjustments as well as labial coupling.
Three disease-dominant subgroups and well as three mixed-disease subgroups were identified. This proposed
project seeks to expand upon these preliminary findings. In Specific Aim 1, we will classify the articulatory
performance profiles of 160 talkers with varying underlying disease types [PD, ALS, MS, Huntington's disease
(HD)]. To allow for a clinical interpretation of the kinematic findings, articulatory performance of talkers with
dysarthria will be referenced to age- and sex-specific control groups. We will also determine which kinematic
measures differentiate talkers with dysarthria and if disease-type varies systematically across articulation-
based dysarthria subgroups. To ensure a rapid translation of our kinematic-based classification approach into
clinical practice we will determine how perceptual-based clinical ratings of articulatory performance map onto
findings of kinematic measures (Specific Aim 2). Raters will judge the articulatory performance of the same 160
talkers with dysarthria using auditory- and visual-perceptual ratings scales. Study outcomes will advance the
field's understanding of articulatory impairment patterns and how they vary in dysarthria. Findings are critical to
elucidate subgroup-specific articulatory mechanisms of intelligibility loss and recovery. Ultimately, this work will
facilitate personalized dysarthria management and the development of new, impairment-specific interventions.

Public health relevance
Project Narrative This project seeks to 1) identify articulation-based dysarthria subgroups derived from articulatory performance profiles of talkers with a variety of underlying neurological conditions using a taxonomic (data-driven) classification approach, 2) determine the articulatory performance characteristics that uniquely differentiate these subgroups, 3) determine if the disease type varies systematically across the identified articulation-based subgroups, and 4) determine the extent to which auditory- and visual-perceptual judgements of articulatory performance map onto the findings of speech kinematic measures. The proposed project is highly relevant to public health and the mission of NIH and NIDCD because it aims to advance our understanding of articulatory impairment patterns and how they may vary across talkers with dysarthria. New discoveries from this project will set the stage for future research efforts that aim to elucidate the subgroup-specific articulatory mechanisms that underlie speech intelligibility loss and recovery in these talkers and facilitate personalized dysarthria management and the development of new, impairment-specific intervention strategies.